Molecular mechanism of TRPV1 activation

TRPV1 is a non-selective cation channel crucially involved in transduction of nociceptive stimuli
into pain signals. Consequently, inhibition of TRPV1 is one of the major strategies for designing
next generation anti-pain drugs. One of the hallmarks of TRPV1 is its polymodal activation
profile; that is, the ability to detect and, remarkably, integrate the information from diverse
environmental factors (e.g. binding of ligands, pH and temperature) to initiate an action potential
in the peripheral ends of sensory axons. From a molecular point of view, this polymodality is the
result of the allosteric coupling between distinct sites acting as "sensors" for the diverse stimuli
and the activation gate. This project investigates the mechanism of this allosteric coupling using
computational biology (molecular dynamics, free energy calculations), state-of-the-art chemical
biology (non-natural amino acids) and electrophysiology. Three fundamental questions raised
by some of our recent research findings will guide our investigation. Aim 1 addresses the
molecular mechanism of activation of TRPV1. The working hypothesis comes from our recently
published computational work whose predictions have been, in part, already verified
experimentally. We found that hydration and dehydration of four hydrophobic pockets present in
the structure of TRPV1 affect the orientation of a conserved asparagine residue in S6; the
rotation of this side chain is, in turn, responsible for the opening of the pore. We will test this
hypothesis with an extensive set of calculations and experiments. Aim 2 Builds on the
observation that wetting/dewetting phenomena show exquisite temperature dependence and
thus provide a viable mechanism for heat activation. This aim is devoted to the quantitative
characterization of the wetting/dewetting thermodynamics and to the experimental testing of our
model using mutagenesis. Finally, Aim 3 investigates the mechanism underpinning TRPV1
regulation by PIP2. Our preliminary data suggest that this lipid favor a conformational transition
of the pore lining S6 helix from a canonical -helix to a non-canonical conformation containing a
segment of -helix. We will test this hypothesis using the combination of computational
modeling, site directed mutagenesis, whole cell and excised patch electrophysiology.

Public health relevance
Project Narrative Chronic pain is an unmet medical need; associated costs have been estimated in the United States at hundreds billions of dollars annually. Intense heat causes pain, and hypersensitivity to thermal stimuli is a major symptom in chronic pain. We study the molecular regulation of TRPV1, an important noxious heat sensing ion channel, and our work has the potential to lead to better therapeutic strategies against pain.